Live-cell Activity Architecture in Cancer

Project summary:
Essential regulation of the cellular machinery is achieved by a network of highly dynamic signaling
molecules, which, when dysregulated, allow cancer cells to misinterpret or ignore signals that normally tell cells
to stop dividing or begin apoptosis, leading to uncontrolled tumor growth. For the last 18 years, my laboratory
has been at the forefront of applying a native biochemistry approach to cell signaling and cancer research. We
have developed enabling technologies, and established spatiotemporal regulation as a fundamental paradigm
in cell signaling, and discovered that its alteration leads to uncontrolled cell growth.
This NCI R35-supported research program seeks to establish a new conceptual framework to
specifically understand the cellular organization of molecular activities. We hypothesize that cellular
biochemical activities are spatially organized into an “activity architecture” and dysregulated driver molecules
can re-organize and re-structure this activity architecture, leading to loss of control over cell growth, division
and death. In the past 6 years, we published 51 peer-reviewed articles, and made significant advances in
establishing this framework. We developed first-in-class technologies for imaging protein-protein interactions
and enzymatic activities in living cells at molecular length-scales and first kinase biosensor that achieved high-
resolution imaging in awake mice, which have provided evidence for the biochemical activity architecture
across different scales. We also made a breakthrough discovery that a regulatory subunit of Protein Kinase A
(PKA), RIα, undergoes liquid-liquid phase-separation (LLPS) to enable the dynamic buffering and spatial
compartmentalization of a ubiquitous second messenger, cAMP, providing an answer to a long standing
question. We further showed that the oncogenic fusion in fibrolamellar carcinoma (FLC) potently inhibits RIα
LLPS and induces aberrant cAMP signaling, which leads to increased cell proliferation and cell transformation.
We have also discovered novel regulation in the Ras/ERK pathway and developed a novel Ras biosensor. In
the proposed research, we will have three focuses. First, we will develop innovative technologies including
super-resolution activity imaging to illuminate the biochemical activity architecture across different scales.
Secondly, we will elucidate how the disorganized cAMP-PKA activity architecture leads to tumorigenesis in
FLC, and further discover novel, cancer-relevant biomolecular condensates. Thirdly, we will investigate the
spatiotemporal regulation of ERK that is critical for its physiological functions and identify the vulnerable
connections in the re-organized cancer-driving architecture in pancreatic cancer, which is a deadly cancer that
is addicted to the Ras-ERK pathway. We will also facilitate the development of new therapeutics by developing
novel assays for evaluating Ras inhibitors and measuring target engagement.

Public health relevance
Narrative: The overall goal of our research is to provide a better understanding of how cancer cells misinterpret or ignore signals that normally tell cells to stop dividing or begin suicide, leading to uncontrolled tumor growth. We will also develop novel assays to facilitate the development of new cancer therapeutics.